Molecular determinants of cell fate in the inner ear

Project Summary: Hearing is a vital sense for nearly all animals, including humans. In mammals, the organ of Corti transduces sound into neural signaling and is well-known for the elegant arrangement of cochlear hair cells into one row of inner hair cells (IHCs) and three rows of outer hair cells (OHCs). This marvel of cellular architecture has appeared in nearly every biology textbook since its description in 1851, yet how IHCs and OHCs differentiate from one another during development is still poorly understood. Hearing loss resulting from inherited mutations and from the loss of hair cells with age, noise, or other insults, affects millions of Americans and countless more globally. In addition, mammalian HCs do not regenerate, and although genetic manipulations suggest that stem cells or nonsensory cells may be converted into cells that resemble hair cells, these cells remain underdeveloped and do not differentiate into mature IHCs or OHCs. Thus, understanding how IHCs and OHCs become distinct cells with complementary functions is of fundamental importance to our understanding of developmental biology and the design of potential otoprotective and regenerative therapies. In this application, we present preliminary evidence that two gene products, p27Kip1 and SIX2, are critical mediators of cell fate decisions leading to IHC and OHC fates, respectively, during cochlear maturation. To test whether p27Kip1 inhibits OHC fate, we propose to delete p27Kip1 from cochlear hair cells, in vivo, and examine the IHCs to see if they adopt OHC characteristics. Conversely, we propose to ectopically express p27 Kip1 in cochlear HCs to test whether exogenous p27Kip1 prevents OHCs from fully differentiating, or causes them to become IHC-like. We further propose to similarly manipulate the expression of Six2 in IHCs and OHCs to see whether the loss of Six2 from OHCs promotes an IHC fate, or if ectopic Six2 expression in IHCs promotes an OHC fate. The altered cell fates in each of these models will be examined by several means including confocal microscopy of fluorescent reporter proteins and immunofluorescent staining to visualize the expression of various proteins that are known to be specific to either IHCs or OHCs. Fluorescent immunostaining will also be used to examine the types of innervation and synaptic connections exhibited by the cells. Sorting of small pools of IHCs and OHCs from each of these models followed by whole transcriptome gene expression analysis (RNA-seq) will further provide an in-depth characterization of the extent of phenotypic conversion of the cells. Finally, scanning electron microscopy will be used to compare the morphological characteristics of the stereociliary bundles which typically differ between IHCs and OHCs. These experiments will allow us to determine whether p27Kip1 and/or SIX2 are critical determinants of IHC and OHC fate and positive results will strongly support future investigation of the roles played by these molecules in hearing function and the potential regeneration of functional hair cells from nonsensory cells.

Public health relevance
Project Narrative: Hearing in mammals relies upon two types of sensory hair cells within the cochlea: inner hair cells and outer hair cells, the latter of which are easily damaged by noise, drugs, and aging. Attempts to reverse sensorineural hearing loss by hair cell regeneration have proven difficult because little is known about how inner and outer hair cells develop. Here we have identified two genes, Cdkn1b (a.k.a. p27Kip1) and Six2, that play key roles in the development and differentiation of inner and outer hair cells, and may be similarly important in the acquisition of normal hearing and the regeneration of functional hair cells.